Administrative

The Administrative Core will provide centralized professional and administrative support to the Program and its Investigators. This includes overall monitoring of progress, organization of weekly meetings of research personnel, facilitation of communications among the units involved on the project, and coordination of the activities of the advisory committees.